Investigating whole-body innate immune activation in Alzheimer's disease using PET imaging and immune profiling

Project Summary/Abstract
The emerging role of inflammation in the pathogenesis of Alzheimer’s disease (AD) is shifting how the field is
approaching its treatment, with growing interest in the development of immunomodulatory therapeutics. The
appropriate therapeutic window and patient population for such treatment strategies remains to be determined.
Importantly, current understanding of inflammation in AD has largely arose from brain tissues studied in isolation.
However, it has become clear that peripheral inflammatory responses may influence both AD risk and disease
progression. Here, I propose to use whole-body positron emission tomography (PET) of the translocator protein
18kDa (TSPO) and triggering receptor on myeloid cells 1 (TREM1) and complementary immune profiling
techniques to non-invasively assess peripheral and central inflammation in Alzheimer’s disease.
This project aims to use parallel preclinical (Aim 1) and clinical approaches (Aims 2 & 3) to increase the
fundamental understanding of inflammation in disease while actively improving clinical assessment. Our specific
aims are (1) to characterize distinct peripheral and central myeloid cell responses and investigate the effects of
systemic inflammation on neuroinflammation in the 5XFAD mouse model of AD; (2) to develop a clinically
feasible approach to quantify whole-body TSPO-PET uptake in AD patients; and (3) to study whole-body immune
signatures associated with disease severity in AD and mild cognitive impairment patients using whole-body
TSPO-PET and blood-based immune profiling.
The innovation of this work lies in the whole-body approach for the investigation of inflammation in AD, which
has yet to be investigated. TREM1-PET is the first tool to specifically image proinflammatory peripheral myeloid
cells in vivo. Preclinical investigation using TREM1-PET and clinical application of whole-body TSPO-PET
imaging in patients will provide novel insights into the complex neuroimmune interactions involved in AD
pathogenesis. The significance of this work is that enhanced understanding of whole-body innate immune
responses in AD has the potential to not only improve diagnosis and disease monitoring, but also to develop and
screen for effective disease modifying therapeutics. Additionally, these methods can be applied to impact our
understanding of inflammation across a broad range of inflammatory and neurological disorders.

Public health relevance
Project Narrative Inflammatory responses in the peripheral and central nervous system appear to play a critical role in the development and progression of Alzheimer’s disease (AD). The ability to non-invasively assess whole-body immune signatures in AD patients is a critical unmet need that will improve diagnosis and disease monitoring, as well as the development and screening of effective therapeutics. This work aims to reveal new insights into the complex neuroimmune interactions involved in AD pathogenesis using novel molecular imaging and immune profiling techniques.